Animal Core

The primary goal of this core is to aid the investigators of the individual projects in generation of sufficient numbers of genetically modifled mice to complete their projects in a timely and efficient fashion. The mouse breeding and genotyping core will be responsible for 1) overseeing the generation and characterization of genetically modified mice; 2) maintenance, expansion and intercrossing of mice lines as needed; and 3) optimization of genotyping protocols for mice containing multiple recombinant genes.